RapidStat: A Hybrid of Spreadsheets and Graphical Language to Expedite User Inter

The purpose of this Phase II effort is to research and develop an innovative approach to empower people who do not have the skills to write programming code or a scripting language, to create simple user interfaces (UIs) to calculation engines written in various programming languages. The requirement includes realizing the approach in a high level programming language and a software system. The system should greatly reduce the time and skills required for a developer to create a UI and connect it to one ore more calculation engines.